Functional Studies of NDD Gene(s)

Project Summary/Abstract
Neurodevelopmental disorders are common, debilitating disorders including autism, intellectual disability,
and perhaps even schizophrenia. Recent genetic findings have identified mutations in multiple genes in various
cellular pathways as genetic causes of rare neurodevelopmental disorders including autism spectrum
disorders, intellectual disability, and others. This proposal will characterize a genetic mouse model, already
generated and breeding in our laboratory, to delineate its function in the brain for the first time. Specifically, the
proposal will be on a gene implicated in a well-defined neurodevelopmental disorder, as well as in autism and
schizophrenia. Because this gene encodes a protein that is known to alter gene expression and chromatin
modifications in non-neuronal cells, we will obtain multiome single nucleus RNA-sequencing and snATAC-seq
data and analyze and correlate these two data sets while examining in parallel chromatin state. These data will
span 3 critical time points during development and two key brain regions. We will also examine morphological
changes in brain subregions using structural MRI as well as the morphology of neurons in the brain of these
mice. A broad behavioral profile including learning/memory, social domain, and repetitive domains will be
obtained to provide outcome measures for future studies. Finally, we will examine synaptic and neuronal
function in two select brain regions using slice electrophysiology approaches. These unbiased, experiments
will identify novel downstream targets in mammalian brain, elucidate behavioral outcome measures for future
studies, and generate new hypotheses anticipated to lead to future potential therapeutic strategies.

Public health relevance
Project Narrative It is critical to better understand genetic causes of human neurodevelopmental disorders such as autism, intellectual disability, and other rare syndromes and to use animal models of such causes to identify potential treatments. This R01 proposal capitalizes on a genetic animal model deleting an understudied gene for autism and neurodevelopmental disorders that will allow us to advance the field. Characterization of this model at molecular, cellular, synaptic, morphological, and behavioral levels will provide important data for future studies including final outcome measures in the mouse model along with hypothesis-generating studies of what downstream genes are altered in a cell-type-specific manner, thereby allowing future studies aimed at correcting altered brain function in the hope of treating behavioral symptoms in both the model and eventually in patients.